Core 1. Ocular Microanatomy Core (OMC)

Summary
The Ocular Microanatomy Core will provide expert technical support for the use of light microscopic systems
for vision research, as well as assistance in quantitative and automated image analysis. The Core will prepare,
embed, cut, and stain histologic sections of ocular tissues, train investigators in microscopic techniques, assist
researchers with image analysis, and maintain existing instrumentation.

Public health relevance
Project Narrative Not require per FOA.